Targeted Therapies in Melanoma

Project Summary -­ Overall

The clinical landscape of melanoma is evolving rapidly, however, a significant fraction of individuals fail to
respond to frontline therapy, and another significant fraction of melanoma patients develop resistance. In
order to improve the response to frontline therapies, we have previously focused on inhibiting survival
pathways, including autophagy, senescence and proteostasis. In the new funding cycle, we extend this
focus toward targeting the melanoma microenvironment.

Targeted therapies designed to inhibit tumor-­intrinsic signaling do not contemplate the influences of the
microenvironment, and the recent success of immunotherapy is a reminder of how important the
consideration of the microenvironment is. Our data are revealing that the normal aging of stromal cells
creates a microenvironment that promotes the activation of signaling pathways that circumvent those
targeted by therapies such as vemurafenib, making the one gene, one drug approach less likely to be
successful. Additionally, the crosstalk between stromal and immune cells in the tumor microenvironment is
vastly underexplored. We believe that genetic drivers in the tumor cell, or specific checkpoints on
immune cells cannot be effectively targeted, without the consideration of the crosstalk between
those cell populations and other cells in the microenvironment.

The Program consists of four well-­integrated projects, from a team that has worked extremely well together
over the last five years, publishing numerous high-­impact collaborative papers. The evolution of this P01
into its new form is truly a reflection of these concerted efforts, evolving from targeting cell fate, to a
realization that cell fate can be differentially affected by its microenvironment. The four Projects are
designed in order to achieve a fully coordinated understanding of how multiple factors (but with a focus on
aging) in the tumor microenvironment contribute to therapy resistance. The alteration of lipid profiles in
stromal, immune and tumor cells is emerging as a key driver of resistance. The Projects will work together
to understand the impact of lipid production, accumulation, uptake, metabolism and catabolism in tumor
cells. Using the novel compounds developed within the current funding cycle of the grant, we will target
tumor/TME crosstalk, and explore novel ways in which to disrupt it.

Public health relevance
Project Narrative - Overall This program project is a renewal from a highly productive team of investigators, which produced 107 publications, >70% of which are collaborations among the team. Overall, our findings in the 2013- 2018 cycle have led to a natural evolution of our studies, where we found that the aged microenvironment is a key contributor to therapy resistance, and that lipid metabolism is a critical regulator of both tumor cell and immune cell response, resulting in forms of cell death such as ferroptosis. Using the tools we have developed in the current funding cycle (dimeric quinacrines, HSP70 inhibitors) and our new understanding of the role of the tumor microenvironment in therapy resistance, this Program focuses on how to overcome resistance and lack of response to therapy by targeting not just the tumor, but also the microenvironment.